Neural encoding of reward and safety

In a dangerous world, the ability to predict safety is paramount. Impairments in predicting safety would lead one to behave as if danger was ever present; while hyperfunction of this predictive capacity would lead one to behave is if danger was nonexistent. Given the shared, positive significance of reward and safety it is hypothesized that reward prediction and safety prediction share a common neural encoding. The basolateral amygdala (BLA) and VS are two brain areas implicated in signaling reward prediction. The objective of the ROO phase of the proposal is to uncover roles for the BLA and VS in safety; learning driven by the omission of aversive events. To this end neurotoxic lesions will be used to describe contributions of the BLA and VS to safety prediction through conditioned inhibition of Pavlovian fear. Single-unit recording will then be used to (1) examine BLA and VS neural activity supporting safety prediction and (2) compare activity supporting safety prediction to activity supporting reward prediction.

Public health relevance
Poor decision-making resulting from addiction to illicit drugs costs Americans billions of dollars annually. This research will describe the neural mechanisms supporting forward-looking prediction of reward and safety. These predictive capacities are the building blocks of decision-making and their neural mechanisms must be uncovered to determine the neural dysfunction underlying poor decision-making in addiction.